NALOXONE

Naloxone administration leads to the release of pituitary ACTH with subsequent adrenal cortisol secretion. In this study we will administer naloxone to AIDS patients and other subjects to determine pituitary- adrenal response to naloxone administration.